Cross-Species Multidisciplinary Training in Alcohol Research

This revised application proposes a new T32 Institutional National Research Service Award with five years of support to fund Cross-Species Multidisciplinary Training in Alcohol Research, comprising four pre-doctoral and two postdoctoral trainees. Virginia Commonwealth University (VCU) has a history of excellence in the alcohol and drug abuse fields, ranking 7th nationally in currently active NIAAA awards (n=36). Major existing research or training funding include: 80 NIDA or NIAAA currently funded projects, NIAAA P50 supported VCU Alcohol Research Center (VCU-ARC), 12 individual F-awards to VCU trainees (7 NIAAA, 5 NIDA), NIDA T32- supported training program now in its 46th year of continuous funding, NIMH T32 training program funded for over 20 years, and a recently funded Medical Scientist Training Program T32. A focal point for alcohol research at VCU is the VCU Alcohol Research Center (VCU-ARC), now in its 12th year of NIAAA support with P50 funding renewed in 2020. VCU-ARC pursues an integrated crossspecies program of genetic, genomic, behavioral and molecular studies to identify genes, gene networks and genetic variants contributing to risk and mechanisms of alcohol use disorder (AUD). VCU-ARC and the overall excellence in alcohol research at VCU make this a fertile training environment across multiple VCU departments or institutes. These include: the Virginia Institute for Psychiatric and Behavioral Genetics (VIPBG) and the Departments of Pharmacology & Toxicology, Human and Molecular Genetics, Psychology, Psychiatry, Internal Medicine and the Program in Neuroscience. The cross-species academic scope will include a 2 year, monthly Foundations of Alcohol Research lecture series, monthly research seminars in VCU ARC, a trainee-led alcohol research journal club, rigorous departmental-specific core courses and advanced electives, a high level of collaboration among mentors to include reciprocal service on thesis committees, multiple excellent seminar series, and required attendance at national or international alcohol research meetings. Specific major program strengths include: i) broad crossspecies expertise of faculty in behavioral pharmacology, psychiatry, genetics, neuroscience, statistics, neuroimaging, data science and psychology; ii) highly productive research environment with accomplished, well-funded faculty; iii) extensive experience and excellent track record of involved faculty in training at this level; iv) access to large, informative datasets collected at VCU; v) instruction in responsible conduct of research utilizing an innovative text from a VCU expert in this field; and vi) This training program thus offers a broad-based, cross-species training in alcohol research in an environment of research excellence.

Public health relevance
There is a shortage of researchers with the high levels of interdisciplinary skills needed to make progress in understanding the etiology and improving clinical treatment of alcohol use disorder (AUD), a major public health problem. The objective of this training grant is to educate the next generation of researchers focused on i) elucidating the risk factors for and outcomes of problem alcohol use, ii) understanding the behavioral and molecular causes and consequences of problematic alcohol use, and iii) contributing to the translation of these basic findings into improvements in both treatment and prevention of AUD. The training in this program aims to educate an interdisciplinary work force of researchers with a solid knowledge of multiple relevant areas, including genetics, behavior, neurobiology, data science and clinical treatment who will be prepared to have an impact on the health of millions of individuals affected by AUD.